Project 1

PROJECT 1
PROJECT SUMMARY
Primary ciliary dyskinesia (PCD) is an autosomal recessive disease caused by mutations in the genes that
encode cilia structural proteins. Mutations in the DNAI1 gene are common in people with PCD and
characterized by loss of the outer dynein arm (ODA) of the ciliary central apparatus and loss of ciliary beating.
The basic physiological defect in PCD is loss of cilia function, yet the clinical presentation is heterogeneous
and includes neonatal respiratory distress, recurrent respiratory tract infections (rhinosinusitis, otitis media,
pneumonia, and bronchitis), bronchiectasis, respiratory failure, infertility, and laterality defects. We generated
a pig model of PCD that recapitulates the key features of human PCD disease. These pigs develop neonatal
respiratory distress, early sinus abnormalities (mucosal thickening and mucus impaction) and early airway
abnormalities (air trapping, lobar collapse, and mucus plugging). With time they develop infection,
inflammation and remodeling of the airways. Most importantly, they do not develop neonatal lethal
hydrocephalus and survive the neonatal stage which allow us to study for the first time the pathogenesis of
early PCD disease and the progression of the disease with time. The overall goal of this Project is to better
understand the pathogenesis of early lung disease in PCD. We will investigate the viscoelastic properties of
PCD mucus, and how its unique characteristics may be an asset for effective cough. We will investigate how
small airways are cleared in the absence of functional cilia. We will investigate the progression of mucus
obstruction, inflammation, and infection in the lungs, and upper airway sinuses. The results of this Project may
lead to novel therapeutic interventions for people with PCD and other airway diseases.

Public health relevance
PROJECT 1 PROJECT NARRATIVE Primary ciliary dyskinesia (PCD) is a common life-shortening disease that causes progressive lung failure due to recurrent infections and chronic inflammation. These studies will use a novel animal model and advanced imaging modalities to understand onset and progression of the disease.